DRUG VS PLACEBO ON CEREBRAL BLOOD FLOW AND METABOLISM IN NORMALS VIA PET

To compare effects of lomefloxacin, ciprofloxacin, and placebo on cerebral blood flow and metabolism in healthy subjects via positron emission tomography.